Urinary Exosomes and COVID-19

---- In 2004, ESBL members were the first to show the presence of vesicular exosomes in human urine, opening the door for a new approach to biomarker discovery for kidney diseases Pisitkun T, Shen RF, Knepper MA. Identification and proteomic profiling of exosomes in human urine. Proc Natl Acad Sci U S A. 2004 Sep 7;101(36):13368-73. doi: 10.1073/pnas.0403453101. Epub 2004 Aug 23. PMID: 15326289). Since then we have published 16 articles exploring methods for isolating exosomes from urine and for analyzing the content of urinary exosomes. At this point, our involvement consists only of advising other scientists and writing review articles.

---- The COVID-19 epidemic resulted in disruption of normal laboratory activities in the Knepper lab, causing a shift of effort to computational and bioinformatic projects to maintain productivity by laboratory members in 2020 and 2021. This project was primary focused on development of analytical and visualization tools useful for understanding the nature of SARS-COV-2 proteins and its receptors in the kidney. These projects are no longer active.